SEARCH: SMS Electronic Adolescent Reminders for Completion of HPV vaccination- Uganda

Cervical cancer is the leading female cancer in Uganda. Many women are diagnosed with late-stage
disease, and 80% of women die within 5 years of diagnosis, making primary prevention critical. HPV is the
principal cause of cervical cancer, making vaccination the single most important primary preventive measure.
The national HPV vaccination program in Uganda began in November 2015 and focuses solely on
preteen/adolescent girls. Two strategies have been adopted for the multi-dose series: 1) school-based and 2)
community-based. However, in Kampala, only 29% of girls receive both needed doses. Reasons for under
vaccination include school absenteeism on special vaccination days for those receiving vaccination as part of a
school program, failing to remember to come to a health facility for a needed dose for those being vaccinated
in the community, and lack of knowledge regarding HPV and the vaccines including vaccine misperceptions.
While research regarding the use of text message vaccine reminders is strong in the U.S., their use has not
yet been demonstrated in a preteen/adolescent population in Sub-Saharan African or other low- and middle-income countries (LMICs). According to the World Bank, currently 89.9% of urban households in Uganda have
a cell phone. This study will take place at three health centres and their affiliated schools and community
immunization centers overseen by the Kampala Capital City Authority (KCCA) as well as at the
Makerere/Mulago/Columbia Adolescent Health Clinic, also in Kampala. While text messages can be used in
populations with low literacy, families can opt to receive automated phone call reminders instead.
R21: Aim 1: Identify desired HPV vaccine text message reminder content (and parallel automated phone
reminders) using key informant interviews We will conduct formative research using key informant interviews
with stakeholders at each site as well as policy makers. Aim 2: Develop and pretest HPV vaccine reminders
with target population We will share prototypes of the designed messages with families to identify issues with
clarity, tone, and persuasiveness. Aim 3: Pilot assess the impact of vaccine reminders on HPV vaccination We
will randomize caregivers of preteens/adolescents at one KCCA site and the adolescent clinic, stratified by site,
language and HPV vaccine dose needed (initiation vs. completion). Feasibility milestones will include reach,
effect size determination and implementation measures. R33: Aim 4: Conduct a full-scale randomized-control
trial to assess the impact of text message reminders on HPV vaccination We will conduct a full-scale RCT
assessing the impact of the HPV vaccine text message reminders. The main outcome will be timeliness of
vaccination. We will also collect process/feasibility measures. This project, if successful, will provide an
important foundation not only for the use of HPV vaccine text message reminders in Uganda but also for other
childhood and adolescent vaccinations in Uganda and in other LMICs.

Public health relevance
PUBLIC HEALTH RELEVANCE This proposed translational research seeks to design and assess, in a randomized controlled trial, text message/automated phone reminders on timely human papillomavirus (HPV) vaccination in Ugandan adolescents. This project, if successful, will outline an important foundation not only for other future trials for HPV vaccine reminders in Uganda, but also for the potential use of text message reminders for other childhood and adolescent vaccinations in Uganda, the larger Sub-Saharan African region, and in other low and middle income countries (LMICs).